Husbandry and Management

PROJECT SUMMARY/ABSTRACT:
For more than two decades, with the support of NIH and of the University of Puerto Rico -Medical Sciences
Campus, the Caribbean Primate Research Center (CPRC) has successfully established and maintained an SPF
(Herpes B, STLV1, SRV and SIV-free) Indian-origin rhesus macaque resource and breeding colony at the Sabana
Seca Field Station (SSFS). To ensure the health of the colony, a solid Animal Care and Use Program is in place.
Mechanisms used to ensure the quality of the colony include routine monitoring by the veterinary staff, IACUC
inspections conducted every six months, USDA inspector visits, and AAALAC site visits every three years. The
Program is also discussed annually with the External Advisory Board (EAB). The Center complies with all federal
and local regulations related to the care and use of laboratory animals and is fully-accredited by AAALAC.The
aims fo this component are: Aim 1: To maintain the closed CPRC- SPF indian-origin rhesus macaque's colony,
at a steady state level, that can provide high quality animals to support numerous NIH funded research projects,
and to continue working toward self-sufficiency. The SPF colony will be maintained in compliance with the
regulatory bodies. Aim 2: To use the projected recovery cost income, as part of an integral financial plan, to
support the CPRC-SPF colony.

Public health relevance
NARRATIVE: This Core describes the solid Animal Care and Use Program in place at CPRC in support of the SPF colony. The Center complies with all federal and local regulations related to the care and use of laboratory animals and is fully-accredited by AAALAC. The SPF colony will be maintained in compliance with the regulatory bodies.